Determining Sox10-mediated plasticity in irradiated salivary gland cells

PROJECT SUMMARY/ABSTRACT
Therapeutic irradiation, a commonly used treatment for head and neck cancer patients, irreversibly damages the
salivary glands (SGs). Current therapies aim to alleviate the resulting xerostomia (dry mouth syndrome) but fail
to address the underlying mechanism of dysfunction, thus new strategies for tissue regeneration are needed.
Given that endogenous repair of irradiated SGs is majorly hampered due to the loss of saliva-producing acinar
cells and their progenitors, inducing the ability of the remaining ductal cells to behave as acinar progenitors (i.e.
plasticity) is an attractive repair strategy. Inducing plasticity is a complex process whereby transcription factors
often interact with chromatin modulators, such as Hdac1, to induce downstream gene regulators of progenitor
cell potency. Interestingly, it has been shown that some irradiated ductal cells can spontaneously revert towards
a progenitor-like state to enable acinar differentiation under severe stress conditions, although too few undergo
this transition to fully restore the gland. In order to enhance plasticity, we recently demonstrated that
overexpression of transcription factor Sox10 in non-irradiated ductal cells induces plasticity, allowing acinar
differentiation ex vivo. However, whether this set-up is applicable to irradiated ductal cells is unclear. Based on
preliminary data, we hypothesize that plasticity can be induced in irradiated ductal cells through overexpression
of Sox10, which activates a downstream regulatory network through binding with Hdac1. To prove this
hypothesis, our objectives are to evaluate the binding capacity of Sox10 to Hdac1, as well as the altered
downstream gene network and acinar formation capacity in irradiated cells after inducing a Sox10-mediated
plasticity. Overall, these data will then be used to formulate a new translational therapy in our in vivo radiation-
induced xerostomia animal model to aid in the repair of SGs post-radiation.

Public health relevance
PROJECT NARRATIVE: Over 500,000 head and neck cancer patients receive therapeutic radiation each year, resulting in irreversible damage to the salivary glands, salivary hypofunction, and subsequent xerostomia (dry mouth syndrome). As current strategies to mitigate xerostomia fail to address the underlying mechanism of dysfunction, new therapies that long-term repair the injured gland are necessary to address this unmet clinical need. Given that Sox10 is involved in SG epithelial stem/progenitor cell self-renewal and differentiation processes, here we aim to determine whether Sox10 can induce plasticity in irradiated salivary gland ductal cells.